ATP1A1-dependent Regulation of Sodium Handling by the Renal Proximal Tubule: Mechanism and Implications in Salt-Sensitivity

ATP1A1 is the only Na/K-ATPase (NKA) isoform expressed in the kidney. As stated in physiology textbooks,
NKA is the enzymatic machinery that powers energy storage in the form of a transmembrane Na+ gradient, which
is essential for renal salt handling and the control of blood pressure. In the renal proximal tubule (RPT), activation
of NKA-mediated classic ion transport function decreases natriuresis through activation of both basolateral (NKA)
and apical (NHE3) Na+ reabsorption. In contrast, activation of the more recently discovered NKA signaling
function triggers a cellular redistribution of both NKA and NHE3 in RPT cells, which decreases Na+ uptake.
Hence, RPT NKA simultaneously serves two opposing roles in Na+ handling: anti-natriuretic through its classic
ATPase-driven ion transport function, and natriuretic through its more recently recognized receptor/signaling
function. To date, the relative contributions of these two NKA functions to the net RPT Na+ handling in vivo is a
fundamentally and therapeutically essential question that has been virtually impossible to answer. NKA signaling,
which is both distinct and independent from NKA classic enzymatic ion-transporting function, was first brought
to the attention of the scientific community by the work of Dr. Zijian Xie in ouabain-treated cardiac myocytes and
renal epithelial cells. Mechanistically, binding of NKA specific ligands such as the cardiotonic steroid (CTS)
ouabain activates Src, resulting in the activation of multiple protein/lipid kinases and the generation of
intracellular second messengers. Numerous groups around the world have expanded the concept of non-
enzymatic signaling function of NKA, while we have focused on the mechanism by which NKA is engaged in
direct interaction with several signaling and scaffolding proteins including Src. This has allowed us to develop
ATP1A1 mutants with intact enzymatic function but defective ability of interaction with signaling partners.
Critically, we have developed a hypomorphic mouse (RPTα1-/-) with a RPT-specific reduction of 70% of NKA α1.
The hyper-reabsorptive renal phenotype of this mouse suggests that NKA signaling is not only physiologically
relevant, but also functionally prevalent in the regulation of RPT Na+ handling. We have established feasibility of
RPT-specific rescue of the hypomorphic RPTα1-/- mouse with either wild-type or Src-binding null mutant forms
of NKA, and propose to use those new tools to test the central hypothesis that NKA α1 (ATP1A1) exerts a tonic
inhibition of apical NHE3 and basolateral Na+ transporters in the RPT. We further surmise that this regulatory
mechanism has a prevalent regulatory role in RPT Na+ handling (Aim 1), depends on NKA α1/Src interaction
(Aim 2), and enables NKA α1 ligands such as CTS to modulate RPT Na+ reabsorption (Aim 3).
Successful completion of the proposed investigation shall reveal a hitherto unrecognized regulatory mechanism
of salt handling by RPT NKA α1, the molecular basis of this regulation, an integrated compensatory transport
network, and their impact on renal physiology and the development of salt sensitivity.

Public health relevance
Mishandling of salt balance by our body contributes to the development and progression of many common diseases, including hypertension and organ damage due to failure to remove excess amount of salt. We propose to demonstrate a new major regulatory mechanism of salt handling by the kidney, and that malfunction of this mechanism by the protein Na/K-ATPase compromises our body's ability to remove salt from the body. Therefore, the proposed investigation has profound basic and clinical implications, and may also provide new targets for developing better therapeutics.